Deciphering Clonal Evolution in Hereditary Renal Cell Carcinomas

1 Background: An improved understanding of the factors that drive cancer growth and progression is
2 fundamental for improving outcomes in patients with cancer. Individuals with Von Hippel-Lindau (VHL)
3 disease develop multiple vascular tumours in their lifetime including many hundreds of malignant
4 cysts and clear cell renal cell carcinoma (ccRCCs). These tumours are the genomic mirror image of
5 sporadic ccRCCs and display variable clinical phenotypes. Profiling multiple, independent tumours
6 that have arisen in an identical germline and host environment offers an intrinsically controlled model
7 to study the factors underlying cancer evolution and progression in general. We will leverage the
8 unique clinical cohort of patients with VHL Disease at the Clinical Centre to study how the molecular
9 landscape (Objective 1), the tumour microenvironment (TME) (Objective 2) and the metabolome
10 (Objective 3) promote or restrain cancer growth.
11 Methods: Subjects will be recruited to this prospective cohort study from the Urology Oncology
12 Branch at the National Cancer Institute. Growth kinetics of individual tumours will be tracked
13 radiologically. During procurement, tumours are identified and correlated with imaging. We will
14 perform multiparametric molecular profiling, integrating all datasets to achieve our study objectives.
15 Using next generation sequencing we will characterise the events that underlie malignant
16 transformation (Objective 1.1) and the molecular events associated with differential growth kinetics
17 (Objective 1.1). We will explore events associated with tumour fromation in extra-renal sites
18 (Objective 1.3) and how molecular/environmental variants influence variable phenotypic penetration
19 amongst VHL kindred (Objective 1.4). To assess the role of the TME, we will use genomic profiling to
20 assess the neoantigen landscape (Objective 2.1) and identify differential immune cell lineages using
21 RNA sequencing (Objective 2.2). We will validate these fidnings with multiplex immunohistochemistry
22 (IHC) approach. We will assess the perturbed metabolome utilising transcriptome profiling (Objective
23 3.1) and conduct a pilot study to assess genomic and transcriptomic changes with stable isotope-
24 resolved metabolic profiles obtained from VHL tumor tissue obtained intraoperatively.
25 Conclusion: This will be the most comprehensive molecular profiling of cancers arising in VHL
26 disease. It has the potential to address key questions regarding evolutionary cancer biology and to
27 identify the triggers for tumour growth and progression and hence predictive or prognostic biomarkers
28 which may have a wider relevance to cancer. It may inform novel therapeutic strategies for the
29 treatment and prevention of hereditary and sporadic ccRCC.

Public health relevance
This translational prospective cohort study of patients with multiple tumours arising on a background of germline VHL mutation aims to comprehensively characterise and understand the molecular events associated with growth and progression of clear cell renal cancer and other VHL associated cancers. We will employ multiparametric tumour profiling to assess how the molecular landscape, the tumour microenvironment and metabolic reprogramming contribute to differences in tumour behaviour. Outputs from this research have the potential to address key question in evolutionary cancer biology: the concept of evolutionary contingency; and in parallel, to identify the triggers for tumour growth and progression, and potentially revealing therapeutic vulnerabilities.